Special Project Analytical Track 1: Sample Collection

PAR-20-105 Laboratory Flexible Funding Model (LFFM) (U19) Special Project Discipline Analytical Track 1: Sample Collection Division of Consolidated Laboratory Services Principal Investigator: Christopher Waggener, Ph.D. SF424: Other Project Information Project Summary: The Division of Consolidated Laboratory Services (DCLS) is the public health laboratory for the Commonwealth of Virginia and offers a wide variety of laboratory testing services for state and federal agencies, local governments and other states in support of public health, environmental protection and emergency response. The Virginia Division of Consolidated Laboratory Services (DCLS) is applying for the FDA LFFM Special Project Sample Collection Analytical Track. DCLS will use these funds for the collection of food samples from retail and manufacturers locations by highly trained food safety specialist employed by the Virginia Department of Agriculture.

Public health relevance
PAR-20-105 Laboratory Flexible Funding Model (LFFM) (U19) Special Project Discipline Analytical Track 1: Sample Collection Division of Consolidated Laboratory Services Principal Investigator: Christopher Waggener, Ph.D. SF424: Other Project Information Project Summary: The Division of Consolidated Laboratory Services (DCLS) is the public health laboratory for the Commonwealth of Virginia and offers a wide variety of laboratory testing services for state and federal agencies, local governments and other states in support of public health, environmental protection and emergency response. The Virginia Division of Consolidated Laboratory Services (DCLS) is applying for the FDA LFFM Special Project Sample Collection Analytical Track. DCLS will use these funds for the collection of food samples from retail and manufacturers locations by highly trained food safety specialist employed by the Virginia Department of Agriculture.